Neurobiology and Genomics Laboratory Core

SUMMARY – CORE 3
The Neurobiology and Genetics Laboratory Core (NGLC) will carry out specialized assays for multiple projects
and thereby insure optimal and comparable reliability across projects. It offers an economy of scale and moves
resources as study priorities change. The assays fall into several major domains. Toxicology assays such as
ones using brain tissue provide a longer time frame on most recent exposure to psychotropic drugs than body
fluids since brain levels tend to be 10-40 times higher. This will be valuable for the postmortem brain studies in
Project 1 where drugs may alter the results. The second domain is genetics and epigenetics. Here assays will
include gene variants, methylation and gene expression assays. The latter domain is applicable to Projects 1,
2 and 5. The core will assay salivary amylase and cortisol in Project 5 and the responses will also be
correlated with findings from Projects 3 and 4. The core will prepare DNA and RNA for assay by the New York
Genome Center checking integrity of the DNA and RNA and preparing samples with the correct concentration
for assay. Other assays for P5 include BDNF, PUFAs, Tryptophan, Kynurenine, Quinolinic acid, Neopterin, and
preparing samples for cytokine assays and assaying cytokines from TSST samples (IL-6, TNF-alpha, C-
reactive protein). Since Project 6 is looking at how suicidal behavior may be predicted by the large imaging
data sets from Projects 3 and 4, it will also consider the impact of the laboratory data from Project 5. Thus,
findings from this core are relevant directly or indirectly to every project